Evolutionary Human Genomics: Demography, Natural Selection, and Transcriptional Regulation

Project Summary
My research program aims to make sense of modern genomic data through the lens of molecular evolution.
Drawing from ideas and techniques in statistics, artificial intelligence, and population genetics, we seek both to
understand the evolutionary forces that have shaped present-day genome sequences, and to use evolutionary
patterns to gain insight into the phenotypic importance of particular genomic sequences, with broad implications
for human health. Our work focuses in particular on three major areas: (1) evolutionary reconstruction based on
genome sequences; (2) inference of the fitness consequences of human mutations; and (3) the study of
transcriptional regulation and its evolution in mammals.
In the last funding period (2018–2022), we achieved major advances in each of these areas, including both
methodological advances and applications of new methods to important and timely scientific questions. For
example, we recently developed innovative new methods for the inference of ancestral recombination graphs
(ARGs) from multi-population sequence data; for the detection of selective sweeps using ARGs and deep neural
networks; for the identification of essential genes from CRISPR-Cas9 screens; for the estimation of relative RNA
half-lives based on widely available RNA-sequencing data types; and for the detection of gains and losses of
cis-regulatory elements along the branches of a phylogeny based on epigenomic data. These methods have all
been implemented as publicly available software tools. Based on these and other methods, we published a
variety of novel scientific findings, including the discovery and characterization of previously unknown
introgression events between modern and archaic hominins; a genomic analysis of South American birds
indicating their radiation was primarily driven by recent selective sweeps; an analysis indicating extensive
evidence of rapid evolution in immunity- and cancer-related genes in bats; and an analysis indicating that
enhancers are gained and lost at about twice the rate of promoters in mammalian evolution. These findings were
described in a total of 17 original papers and preprints.
For this renewal application, we propose to continue our research within each of these three key areas. Specific
goals include developing new statistical sampling methods that scale to very large ARGs; using domain
adaptation to reduce training bias in population genomics; measuring extreme levels of purifying selection from
patterns of rare variation in human populations; characterizing the distributions of fitness effects for polygenic
traits; identifying and characterizing deleterious variants linked to advantageous alleles; and developing a unified
biophysical modeling framework for nascent RNA sequencing data with applications to comparative genomics
and elongation-rate estimation. A renewal of R35 funding will enable us to remain highly productive contributors
to this critically important research area.

Public health relevance
Project Narrative Vast quantities of genomic data are now available to describe patterns of genetic variation and gene expression both within human populations and across species. These data need to be interpreted in light of the fundamental forces of mutation, recombination, natural selection, and genetic drift that have shaped our genomes over millions of years of evolution. This proposal describes a series of projects that make use of new computational methods to address fundamental questions in human evolutionary genomics, including how human diversity has been shaped by introgression from our archaic hominin cousins, how new mutations influence human health and fitness, and how the evolution of gene expression contributes to unique aspects of human biology and disease.